Administrative/Biostatistics Core

PROJECT SUMMARY (Administrative / Biostatistics Core)
The SuperAging Consortium includes a network of Sites, Cores, multidisciplinary data collection and two
Projects. The Administrative/Biostatistics Core will provide governance and fiscal oversight, maintain scientific
integrity, deliver data management and biostatistical support, and harmonize the goals and activities of the
Cores, Sites, Research Projects, with each other, with the NIA and with extramural collaborators for the
SuperAging Consortium. The Admin/Biostats Core will play a pivotal role in integrating the components of the
Consortium so the whole is more than the sum of its parts through three Aims. Aim 1 will provide overall
leadership, operational, and administrative support for the SuperAging Consortium including coordinating regular
meetings among Cores, Projects, data collection Sites, managing reporting, monitoring, financial and regulatory
aspects of the proposal. Aim 2 will establish an Executive Committee with regular meetings and leadership from
each of the components of the SuperAging Consortium and the NIA to proactively facilitate research, and
promote the productive utilization of resources generated by the SuperAging Consortium. Aim 3 will appoint a
Scientific Advisory Board (SAB) and ensure their recommendations are implemented. Aim 4 will develop and
manage a tightly integrated data repository and provide biostatistical support for the SuperAging Consortium.
Collectively, these efforts will enable efficient completion of the investigations outlined here as well as additional
intramural and extramural collaborative ventures.